Wolbachia disrupts eukaryotic endolysosomal membrane dynamics

PROJECT SUMMARY
Filarial nematodes of the family Onchocercidae cause debilitating human diseases, such as lymphatic
filariasis. As approximately 150 million individuals are currently infected with these nematodes, obtaining in-
depth knowledge of pathogen biology will serve to address a global health issue. It is known that the filarial
nematode, Brugia malayi, harbors an intracellular endosymbiotic bacterium of the Wolbachia genus, and this
relationship is essential; clearance of Wolbachia from the nematode with antibiotics leads to eventual nematode
death. Understanding the mechanisms by which Wolbachia maintains its intracellular survival within nematodes
would therefore likely provide an important avenue towards controlling pathogenic nematode populations, but
both Brugia and Wolbachia are not amenable to genetic manipulations. Discoveries of important
bacterium:nematode interactions at the molecular level, therefore, have proven exceedingly difficult.
In this proposal, our goals are to utilize proteins from Wolbachia to genetically and biochemically dissect
conserved pathways of endolysosomal membrane dynamics in yeast. These secreted “effector” proteins are
known to alter host processes in order to support the survival of the bacterium in the eukaryotic host and to
ensure its own reproduction, and are therefore potent reagents that impact eukaryotic physiology. To this end,
my laboratory has employed the budding yeast, Saccharomoyces cerevisiae (Sce), as a model system towards
the discovery of bacterial proteins that modulate eukaryotic cellular biology, with a focus on those proteins which
inhibit intracellular membrane fusion and protein trafficking pathways.
In a previous screen of candidate wBm secreted effector proteins, we have already identified proteins
from wBm that have the ability to manipulate eukaryotic biology. In this work, we show that one such protein,
wBm0152, strongly inhibits endosome:vacuole trafficking pathways in vitro. This inhibition appears to result from
modulation of the conserved ESCRT complex. As wBm is known to alter membrane dynamics in its host during
its symbiosis, and coupled with the fact that regulation of membrane dynamics is strongly conserved throughout
eukaryotes, the detailed genetic, molecular, and biochemical studies carried out in this proposal will be applicable
to wBm:B. malayi interactions, and thus, human filarial diseases. Finally, leveraging our laboratory's strengths
in microbiology, cellular biology, and protein/ lipid biochemistry, we will carefully detail the biochemical activity of
this Wolbachia-derived ESCRT modulator and identify important regulators and binding partners in yeast, which
are likely conserved in Brugia. This work will begin to describe heretofore unknown wBm:B. malayi interactions,
thus providing novel insight into not only Brugia physiology, but also provide new insight into ESCRT-dependent
activities in eukaryotes.

Public health relevance
PROJECT NARRATIVE Filarial nematodes from the family Onchocercidae, including Brugia malayi, cause the devastating human filarial diseases, elephantiasis and river blindness. These nematodes can only cause disease in humans if they are also infected by a bacterium, Wolbachia pipientis. Understanding mechanisms of Wolbachia survival within these nematodes can provide new information towards the treatment of human filarial diseases and a fundamental understanding of pathogenic nematode biology.